Modeling HIV and methamphetamine-induced neuroinflammation in cerebral organoids

Combination antiretroviral therapy (cART) has led to dramatic increases in lifespan among HIV-infected
individuals. Despite effective cART, however, HIV-associated morbidities exert a significant toll. HIV-
associated neurocognitive disorders (HAND) occur in up to 50% of chronically infected individuals despite
cART. The pathogenesis of HAND remains under investigation. Neuroinflammation is a hallmark of HAND,
as established by clinical studies, autopsy studies, and animal models. Ongoing or intermittent replication of
HIV in the CNS is likely to contribute to neuroinflammation through direct effects on the infected cells or
through release of viral proteins and inflammatory mediators. Use of neural stimulants including
methamphetamine can exacerbate the neurocognitive decline seen in HAND, but the mechanisms
underlying this comorbidity are not understood. Microglia are the primary resident myeloid cells of the brain,
are infected at early times following acute infection with HIV or SIV, can act as a CNS viral reservoir, and
are thought to play a central role in the development of HAND. The pathways responsible for microglial
activation and dysfunction following HIV infection remain incompletely defined. Microglia derived from
induced pluripotent stem cells (iPSCs) provide a unique opportunity to examine the molecular mechanisms
underlying microglial activation. iPSC-derived microglia will be introduced into cerebral organoids, providing
the additional opportunity to define the effects of microglial activation on surrounding astrocytes, neurons,
and other cells. Tetherin is a host restriction factor that captures HIV during the assembly process in
infected cells and generates a proinflammatory signaling cascade within infected cells. Experiments in Aim
1 of this project will evaluate HIV-induced neuroinflammation both in an unbiased way and through a
directed evaluation of the role of tetherin-mediated signaling as a trigger of microglial inflammation.
RNAseq, cytokine production, and immunofluorescence microscopy will be employed to define microglial
activation following HIV infection. In Aim 2, we will introduce HIV-infected microglia into cerebral organoids
to define the molecular basis of HIV-induced neuroinflammation and neuronal dysfunction. Single-cell
RNAseq and evaluation of neuronal health and electrophysiology will be performed in models representing
acute infection and in ART-suppressed, chronic infection of the brain. The potential of methamphetamine to
contribute to neuroinflammation and neuronal damage in the HIV-infected microglia/organoid model will
then be defined, and the relevant pathways identified. Together, these studies will provide insights into the
pathogenesis of HAND and the potential contribution of methamphetamine to neurocognitive decline.

Public health relevance
Project Narrative: This project will utilize microglia and cerebral organoids derived from induced pluripotent stem cells to study how HIV causes inflammation and neuronal damage in the brain, leading to HIV-associated neurocognitive disorders (HAND). Signaling pathways that result in inflammation following HIV infection of microglia will be a focus of investigation. The mechanisms underlying the adverse effects of methamphetamine on the HIV- infected brain will defined in this model system.